Developing a Young Adult-Mediated Intervention to Increase Colorectal Cancer Screening among Rural Screening Age-Eligible Adults

PROJECT SUMMARY
Colorectal cancer (CRC) remains the second leading cause of cancer-related death in the United States. Recent
studies have highlighted several geographic, primarily rural, “hotspots” for excess CRC incidence and mortality.
One driver of these disparities between rural and non-rural populations is low CRC screening rates in rural areas.
Thus, novel methods for improving screening and early detection in these areas are needed. The long-term
objective of this research is to develop an intervention leveraging “upward communications” to improve CRC
screening uptake in rural populations. The proposed R03 specific aims will help achieve this objective by
garnering the preliminary information needed to develop a young adult-mediated intervention whereby a younger
family member is taught to encourage their older family member to engage in CRC screening. Such an
intervention could not only improve screening uptake among age-eligible adults, but could also improve cancer
screening knowledge, awareness, and readiness among young adults themselves living in rural settings. The
ORBIT model will guide the process of deliberatively developing and optimizing the intervention approach. Aims
1 and 2 will use mixed methods to collect formative data to identify critical intervention components. To complete
Aim 1, survey data from n=150 younger (25-44 years old) and n=150 older (45-75 years old) adults living in rural
communities will be collected. In Aim 2, we will develop and evaluate intervention components to facilitate
effective upward communications about CRC prevention and screening using n=9 focus groups. We will iterate
and modify intervention components based on focus group feedback. The results from Aims 1 and 2 will guide the
refinement of intervention content and design. The impact of the novel intervention will be assessed via a single-
arm, pre-test post-test trial design (n=15 adult child/parent dyads) in Aim 3. Tapping into and leveraging family
members may be a particularly salient channel for culturally appropriate cancer communications in rural
populations and may help address the unmet needs of CRC hotspot residents. Collectively, the proposed
research will produce an upward communications intervention that has the potential to improve CRC health
literacy and screening uptake in rural settings.

Public health relevance
PROJECT NARRATIVE Suboptimal colorectal cancer screening uptake leads to excess morbidity and mortality, especially within rural populations. Consistent with the R03 mechanism, the proposed research will provide fundamental knowledge about opportunities to leverage “upward communication” in rural settings whereby a younger family member is taught to encourage their older family member to engage in colorectal cancer screening. The carefully designed series of specific aims will afford the preliminary data necessary to develop a young adult-mediated intervention to increase colorectal cancer screening and awareness among paired screening age-eligible family members.